Mentoring Training in the Research Environment at the University of Rochester Medical Center and College of Arts, Sciences & Engineering

Project Summary/Abstract
Mentoring in the research environment is a central element of training, health, and future success of the next
cadre of biomedical researchers. Despite our success in training, as is evident by the records of past trainees,
we recognize a burgeoning need for additional training in mentoring as students prepare for diverse careers
and face ever-increasing stressful challenges related to research and career training that are amplified by the
current social media environment. This supplement application aims to provide critical training to both mentors
and mentees by mounting a six-part series of sessions led by Dr. Jeffrey Ring, PhD, a renowned expert and
experienced health psychologist, author, and leadership coach, offering consulting and training around issues
of implicit bias and curbing health inequities, and mental health of trainees. His consulting expertise includes
professional coaching for enhanced leadership, effective team functioning, and effective mentoring. The
training will be offered within the context of our NIH T32 GM135134, funded for years 2020-2025, but, in part,
will be made available to all students and faculty at the URMC. A key feature of this training is the engagement
of Cathleen Daniels Cerosaletti from the Warner School of Education at the University of Rochester, who will
help develop and implement a comprehensive evaluation plan. She has over 30 years of experience
performing research and evaluation using a wide array of qualitative and quantitative social science methods
and is an experienced STEM educational evaluator for multiple NIH and NSF programs. The tools developed
for evaluation of the training described in this proposal will be further adapted for the future assessment of
activities of the overall training program.

Public health relevance
Project Narrative The public health relevance of the proposed Administrative Supplement to NIH T32GM135134 is to support efforts in hands-on training for both mentors and mentees at the University of Rochester through the efforts of Jeffrey Ring, a professional leadership coach. We will also implement a comprehensive evaluation plan in collaboration with Cathleen Daniels Cerosaletti, from the Warner School of Education at the University of Rochester, who has extensive experience in quantitative and qualitative assessments. The Supplement aims to initiate efforts to augment the health and well-being of our scientists toward their leading productive professional and personal lives.